High throughput CAR-T potency assay based on functional and transcriptional measurements on single cell co-cultures

ABSTRACT
Over the last decade, cell based “living medicines” like chimeric antigen receptor (CAR)-T cell immunotherapies
have led to miraculous cures in advanced and aggressive leukemias and lymphomas in children and adults.
Prior to their introduction, these cancers were thought to be virtually untreatable, yet multiple clinical trials have
now shown that administering CAR-T therapy can be even more effective than chemotherapy, the standard of
care. Despite its great promise, many barriers continue to limit the potency of CAR-T therapies in treating solid
and liquid tumors, and it is still not clear which biomarkers have the most clinical relevance. Unlike molecular
therapies, such as small molecule drugs and biologics, which can be homogenously produced from batch to
batch, cell-based therapies are inherently heterogeneous, and there are still many unknowns about which
specific subpopulations contained in these “living medicines” contribute to overall therapeutic potency. Clinical
data has consistently shown that the overall immune response is often dominated by relatively few CAR-T clones
that both kill the target and rapidly proliferate after infusion. However, to date it has not been possible to further
quantify these killer, proliferative subpopulations, due to our inability to measure these diverse functions
simultaneously at the level of each single cell. To provide a more comprehensive solution for analyzing CAR-T
potency, Celldom is commercializing a platform that can measure the functional properties of >100,000 CAR-T
effector cells in co-culture format in a single experiment, and then use these functional measurements to make
real time decisions about which cells to retrieve for genomic characterization. Our platform uses proprietary
microwell plates to isolate discrete single cell co-cultures using simple workflows involving only liquid handling
tools and centrifugation. We have built an imager that can maintain the viability of co-cultures over many days,
while continuously monitoring multiple phenotypic parameters, such as cytotoxicity activity, and growth rate. With
support from this proposal, we aim to include additional measurements of cytokine secretions, cell surface
markers, and gene expression. In order to achieve this goal, we need to realize a combination of technical
engineering milestones and immunological assay development milestones. Our engineering objectives are to
apply video action recognition models to improve the accuracy of cytolysis measurements and coculture
detection, and to establish a real-time image acquisition and computer vision data analysis pipeline that allows
clones to be picked immediately at the end of the experiment. Our assay development objectives are to assess
the range and limits of detection for 3 cytokines and 3 surface markers, to add these selection criteria for clone
isolation. We further aim to retrieve high priority clones from specific microwells to analyze the transcriptional
states and clonality of different sub-populations. Once all of these capabilities are in place, Celldom will have the
most comprehensive platform on the market for measuring functional and molecular properties of individual T
cells, which can help identify and further study the subpopulations that dominate the in vivo response.

Public health relevance
NARRATIVE “Living medicines” like chimeric antigen receptor (CAR)-T cell immunotherapies have led to miraculous cures in aggressive leukemias and lymphomas in children and adults. Since each drug lot serves only one patient, manufacturing and QC testing must be performed individually on every patient sample; however current potency testing platforms are unable to reliably predict clinical outcomes. To solve the need for a more comprehensive CAR-T potency assay, Celldom is developing a platform that combines image-based phenotyping with molecular profiling at the massive scales necessary to measure the ability of CAR-T effector cells to kill their targets, proliferate, and produce molecules necessary to mount a defense against antigen-expressing tumor cells.